Bio-Social Pathways Linking Socioeconomic Adversity to Obesity

PROJECT SUMMARY
Over the past 40 years, the prevalence of obesity has increased markedly in the US—doubling among adults
and disproportionately affecting racial/ethnic minorities. This has increased the clinical, social and economic
burden of cardiovascular disease (CVD) for the public, and especially so for minorities. CVD and its antecedent
risk factors (i.e., obesity, dyslipidemia, inflammation, elevated blood pressure) also display notable disparities
in risk. For example, obesity risk varies by socioeconomic status, SES, i.e. by educational attainment, income,
occupational status; yet, it is unclear exactly how socioeconomic adversity is translated into the biologic
changes that lead to greater disease burden. Epigenetics provides a framework for testing how adverse
environments and life experiences change biologic processes and shape disease risk. Our study will leverage
~9,000 ancestrally diverse individuals four large racially/ethnically diverse NIH-funded cohorts: Atherosclerosis
and Risk in Communities (ARIC), Women’s Health Initiative, Jackson Heart Study, and the Multi-Ethnic Cohort
Study with existing data to test if DNA methylation is a biologic mechanism through which SES leads to obesity
and downstream cardiometabolic dysfunction. Our preliminary analyses in ARIC African Americans identified
differential DNA methylation associated with components of socioeconomic adversity at several obesity-related
genes, lending strong and convincing support for our innovative hypotheses. Herein, we propose a
comprehensive analysis of extant methylation data from five race/ethnic groups using a composite score of
SES as well as multiple obesity measures. Our two specific aims will: 1) identify DNA methylation sites that
mediate the association between socioeconomic adversity and obesity, independent of local genetic variation;
and 2) integrate all available bio-social data to model the pathways between SES, obesity and ultimately CVD
outcomes. Funding from this grant mechanism will allow us to describe extent that DNA methylation sites are
associated with SES and/or obesity, and how these changes (or their interactions with SES) vary across
race/ethnic groups to contribute to CVD disparities. Our study is innovative due to its unprecedented
integration of survey, examination, and DNA methylation-typing on an ancestrally diverse sample. This
project’s anticipated findings will improve both our mechanistic understanding of obesity and CVD, and our
ability to identify potentially-actionable public health or pharmacologic interventions for CVD in diverse
populations.

Public health relevance
NARRATIVE Obesity is one of the largest public health challenges, with stark disparities across racial/ethnic and socioeconomic classifications. This research proposal will identify the epigenomic changes that link socioeconomically adverse life circumstances to obesity and cardiovascular disease in a racially/ethnically diverse sample. Our research team has years of collective experience in epidemiology and health disparities research, which we will put to use in our proposed study of how social exposures and biology interact to impact obesity and cardiovascular disease in diverse populations.